Research Experience and Training Coordination Core

RETCC Summary
The Columbia University Northern Plains Superfund Research Program (CUNP-SRP)’s mission is to advance
science and technology to improve water quality and mitigate metal-related health effects in tribal communities
in the Northern Plains and other rural and suburban communities affected by groundwater contaminants,
including those near Superfund sites and abandoned mines. The CUNP-SRP research Projects and Cores use
systems science, local community knowledge, and cross-cutting technologies to provide an ideal framework for
interdisciplinary research and training. Leveraging these CUNP-SRP opportunities, the Research Experience
and Training Coordination Core (RETCC) will train a diverse group of future leaders who can traverse biomedical
and earth sciences research to accelerate innovation, incorporate community input, and improve public health
through the following aims. (1) Provide rigorous training in disciplinary, interdisciplinary, participatory, and
translational research through a shared curriculum that includes Indigenous research ethics, exposure science,
data science, and teamwork. Trainees will work with the Data Management and Analysis Core (DMAC) and
Project scientists to analyze high-dimensional data using contemporary statistical approaches following
comprehensive training in participatory research ethics. (2) Enable hands-on skills that underscore real-world
applications of the trainees’ field and laboratory research through their participation in Community Engagement
Core and research translation activities, including opportunities to work with tribal organizations and communities
to mitigate water contaminants and related health effects. (3) Develop leadership skills to prepare trainees for
successful and diverse careers, enabling them to take ownership of several CUNP-SRP aspects including
seminar speaker selection, journal club organization, mentoring high school students from the Northern Plains,
and development of their own scientific and creative initiatives. (4) Promote diversity in environmental health,
earth sciences, and engineering by recruiting and supporting graduate and postgraduate trainees of diverse
backgrounds and perspectives into the RETCC, including candidates who are Native Americans. RETCC
Leaders and CUNP-SRP investigators will engage in departmental admission committees to review candidates
as well as in recruitment efforts, including networking with Northern Plains colleges, to encourage and support
eligible students to apply to our programs. The RETCC is designed to unite trainees (typically 15 trainees at any
given time, including graduate students and postdoctoral scholars) from across Columbia University’s Mailman
School of Public Health and Lamont-Doherty Earth Observatory to provide interdisciplinary training in public
health, medicine, earth sciences, and engineering. Successful accomplishment of the proposed aims will yield
alumni who are proficient in their chosen disciplines and in interdisciplinary research, with real-world
perspectives, a strong set of practical skills, respect for communities, and leadership qualities that will enable
them to launch their careers as successful environmental health and earth scientists and engineers.

Public health relevance
RETCC Narrative The Research Experience and Training Coordination Core (RETCC) will train a diverse group of future leaders who can traverse biomedical and earth sciences research to accelerate innovation, incorporate community input, and improve public health. The Columbia University Northern Plains Superfund Research Program’s mission to advance science and technology to improve water quality and mitigate metal-related health effects in tribal communities in the Northern Plains uses systems science, local community knowledge, and cross-cutting technologies which will provide an ideal framework for this interdisciplinary research and training. Successful accomplishment of the proposed aims will yield alumni who are proficient in their chosen disciplines and in interdisciplinary research, with real-world perspectives, a strong set of practical skills, respect for communities, and leadership qualities that will enable them to launch their careers as successful environmental health and earth scientists and engineers.